NIDDK Data Repository Transition Out

The NIDDK Central Repository program established a closeout contract to ensure the successful transition of the NIDDK Data Repository, allowing time for a seamless transition to a new Data Repository contractor with minimal disruptions to routine Central Repository operations and support to NIDDK-funded research projects.